Counter Bias Training Simulation (CBTsim) Healthcare: A Novel Approach for Reducing the Impact of Implicit Bias on Healthcare Delivery

ABSTRACT
Bias in how clinicians form relationships with and treat patients exists based on patient race, ethnicity,
gender, socio-economic status, LGBTQ+ status, disability, addiction and other factors. Implicit or
unconscious biases (the ways in which our beliefs, attitudes, and values influence how we see the world
and the people in it) are widespread and affect patients’ health outcomes. Our team has developed Counter
Bias Training Simulation (CBTsim), an innovative and unique training program that uses simulation to
reduce the impact of implicit bias on how people interact and make decisions that affect others. Versions
have been developed for policing and military professionals to enhance their ability to interact with diverse
groups of citizens in unbiased ways. CBTsim has great relevance to healthcare, for which existing bias
trainings are typically video or lecture based, and may be ineffective at reducing the impact of bias on
patient-clinician relationships (PCR) and consequent healthcare delivery. The purpose of this study is to
develop “CBTsim Healthcare” and evaluate its effectiveness at reducing bias in how nurses treat their
patients. The proposed study will be jointly conducted in the Washington State University College of Nursing
Simulation Lab and Providence Medical Center in Spokane. First, we will develop CBTsim Healthcare
scenarios based on an extensive review of the literature on healthcare disparities. Then, we will conduct a
randomized control trial with 100 nurses to test the effectiveness of CBTsim Healthcare. Nurses will receive
2 hours of baseline testing, then 50 (treatment group) will receive a 4-hour CBTsim Healthcare training and
the other 50 (control group) will watch a 1-hour video on implicit bias in healthcare, typical of current
standard practice. Then, all 100 nurses will receive 2 hours of post-intervention testing. Testing will include
the implicit association test (IAT) to measure implicit bias, questionnaires to measure prejudice, and patient
care scenarios using simulation mannequins to test for bias in PCR and other aspects of healthcare
delivery. Finally, we will track treatment and control group nurses in the hospital for 6 months following the
intervention to assess disparities in healthcare, measured using patient satisfaction with nursing care scales
(quantitative measure) and narratives to document experience of PCR (qualitative measure). All major
health agencies have identified reduction of implicit bias in healthcare and resulting minority health
disparities as a matter of extreme importance and urgency. The economic impact of health disparities is an
estimated $230 billion a year, and the social justice impact is immeasurable. Our current focus on nurses is
due to our existing relationship (e.g., on AHRQ R01 HS025965-01), however we anticipate that CBTsim
Healthcare could be modified for other healthcare professional groups and could have a revolutionary
impact on reducing bias in healthcare delivery nationwide.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will investigate a novel method of reducing the impact of implicit bias on therapeutic relationships, healthcare delivery, and consequent patient health outcomes. This could have a revolutionary impact on reducing bias in healthcare delivery and resulting health disparities nationwide. This project directly responds to recommendations from several institutes and research groups who have identified reduction of implicit bias in healthcare and resulting health disparities as a matter of extreme importance and urgency, including the National Institute of Health (NIH), the Agency for Healthcare Research and Quality (AHRQ), and the Center for Disease Control (CDC).